Randomized trial of a data-driven technical assistance system for drug prevention coalitions

Project Summary/Abstract: The overall goal of this five-year R01 study is to test the Coalition Check-Up
(CCU) technical assistance (TA) system for supporting community coalitions’ implementation of evidence-
based drug prevention programs (EBPs). Community coalitions are a cornerstone of federal drug prevention
policy but have only demonstrated efficacy in preventing substance use when they implement EBPs, a
capacity many lack. CCU TA supports coalitions in identifying and addressing gaps in their EBP
implementation capacity. The proposed study advances implementation science by applying Wandersman’s
Interactive Systems Framework to test the effects of CCU on coalition EBP implementation capacity and youth
outcomes. Despite the popularity of drug prevention coalitions as a mechanism for EBP dissemination, there
has been little research on how to effectively support coalitions for optimal EBP implementation. Lacking
adequate support, coalitions and EBPs often fail, and TA as provided in evidence-based coalition models is
often too expensive to scale in real-world settings. The CCU provides a lower-cost TA system that is broadly
applicable across coalition models. Our main objective is to test the overall effectiveness of the CCU, including
how it contributes to EBP implementation and prevention of youth substance use. Building on the Interactive
System Framework, our central hypothesis is that the CCU, as part of the implementation support system,
increases coalition capacity for EBP implementation, thereby increasing the probability that EBPs will reduce
youth substance use. We will test this central hypothesis and our larger conceptual model by pursuing three
specific aims. The first aim is to estimate the impact of the CCU on coalition capacity. Coalitions will be
randomly assigned to the CCU or a ‘data report without TA’ condition to evaluate whether the CCU improves
coalition capacity as measured by coalition member reports of team processes, network composition, and
collaborative structure. The second aim is to estimate the impact of the CCU on the implementation of EBPs,
including EBP reach, implementation quality, and sustainability. The third aim is to estimate the impact of the
CCU on youth substance use. The CCU is innovative in its emphasis on proactive monitoring and data-driven
TA, its use of motivational interviewing to enhance coalition-driven action planning, and its examination of
network structure to enhance coalition capacity. The proposed study’s contribution is highly significant because
the field currently lacks clear evidence of the effectiveness of a TA model applicable to the heterogeneous mix
of drug prevention coalitions in operation. The research will enhance community coalition ability to bridge the
research to practice gap in drug prevention programming. Results are expected to have a positive impact on
the field by establishing the evidence-base for a low-cost, data-driven, manualized TA model that identifies
how to intervene with community coalitions to support sustained implementation of evidence-based drug
prevention programs and policies known to promote community health.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health because it tests an intervention designed to enhance drug prevention community coalition capacity and improve evidence-based drug prevention program implementation, thereby reducing youth drug use. Thus, the proposed research is relevant to the part of NIDA's mission of ensuring the rapid and effective dissemination of research findings to significantly improve the prevention of drug abuse and addiction.